Binding Kinetics in Transcription Activation and Repression

Transcription regulation is a key determinant of how genetic variability is interpreted by a cell: more than 90%
of traits- and disease-associated genetic variants map outside of the coding genome. While we now have a
robust understanding of where human TFs might bind, enabling predictions of TF binding when data is
unavailable, those approaches do not tell us how frequently a TF binds, how long it stays bound, and what it
does once bound, which makes it difficult to predict the impact that TF or regulatory site variants will have on
transcription.
Critical regulatory architectures, primarily studied with activators, typically favor transient, lower affinity
interactions between regulators and the DNA over stronger ones. This is consistent with observations that the
transcription machinery can load very efficiently, within seconds. Whether similar strategies are adopted by
repressors is unclear, given the much longer timescales over which repression unfolds.
In this proposal, we will build upon a novel AI-based Zinc Finger design model to engineer synthetic mimics of
endogenous DNA binding domains that bind arbitrary sequences with tunable affinity and measure their
binding kinetics in reconstituted assays. We will deploy cutting-edge single-molecule tracking microscopy in
order to measure the binding kinetics of these domains to their targets and at non-specific site inside living
cells. These experiments will enable reconstructing the strategies deployed by Transcription Factors to find
their targets in the genome haystack.
We will fuse these DNA binding domains with activating or repressing domains in order to directly link
Transcription Factor binding kinetics to the timing and output of transcription bursts synthesized by their target
genes. Together, these data will provide mechanistic access to the strategies that repressors and activators
have evolved to find and regulate their targets. The results constitute key design principles for novel
biotechnologies based on Transcription Factor reprogramming.

Public health relevance
Project Narrative Transcription regulation is a key determinant of how genetic variability is interpreted by a cell: more than 90% of traits- and disease-associated genetic variants map outside of the coding genome; yet we still have a limited understanding of the how Transcription Factors find their target sequences in the genome haystack. In order to address this challenge, we will build upon our ability to design Zinc Finger containing Transcription Factors that bind arbitrary DNA sequences and combine it with cutting-edge live imaging approaches able to visualize where Transcription Factors bind in the cell. We will address whether Transcription Factors that turn genes on or off have evolved distinct strategies to find their targets, which will provide important design principles for novel biotechnologies based on Transcription Factor reprogramming.